Impact of Advanced Imaging and Enhanced Risk Profiling on Mitral Valve Prolapse

SUMMARY: Mitral valve prolapse (MVP) is a common cardiac condition that is frequently associated with trace
to mild mitral regurgitation, is usually asymptomatic, and most often ignored. When MVP progresses to significant
regurgitation, patients may develop heart failure, atrial fibrillation, and pulmonary hypertension and is a frequent
indication for intervention. However, MVP is a phenotypical presentation of numerous underlying diseases and
is commonly encountered in collagen vascular disorders and a large variety of congenital disorders. Underlying
tissue characteristics including fibrosis of the left ventricle and papillary muscles, and mitral annulus disjunction
are associated with MVP, predispose to ventricular arrhythmias which may be fatal, and do not necessarily
correlate with severity of MVP and regurgitation. The purpose of this project is to enhance the clinical
identification of people who are at risk of moderate to severe MVP or have associated factors that indicate risk
of unexpected health events or complicate the treatment. In Aim 1, this project will describe the history of MVP,
related cardiac morbidities, and other conditions that may contribute to or identify the risk of poor health
outcomes. This will involve evaluation of a large population in Intermountain Health, a health system with more
than 30 years of data warehousing of electronic health record (EHR) data. Intermountain’s 33 hospitals, 385
medical clinics, and integrated services provide health and healthcare services to people across 7 mountain
states and includes a broad rural health component. Outcomes will include MVP diagnosis and post-diagnosis
health events. For Aim 2, the project will evaluate heritable risk factors for MVP endpoints. This will first leverage
a unique population genealogy of tens of millions of people in family pedigrees and linked EHR data to examine
familial risks. It will also employ a large-scale genetic testing project with hundreds of thousands of participants
to evaluate polygenic risk scores. Unfortunately, no risk stratification nomogram exists for assessing MVP risks
and predictors of MVP onset and progression are reported in piecemeal form, thus in Aim 3, drawing together
clinical and genetic risk prediction approaches, a novel set of clinical decision tools will be created using EHR
data to empower the identification of people who are at risk of MVP-associated outcomes. Most importantly, this
will include multivariable risk equations for stratifying risk of severe health endpoints for people with MVP that
can be used to inform risk assessment and clinical care plans in guiding management and treatment of people
with elevated risk of death or major health events. One set of risk models will be developed with the aim of
creating a clinical decision tool that predicts a near-maximum amount of variance in risk using a parsimonious
set of clinically-available factors that can be used in the EHR background to calculate a risk score that the EHR
delivers to the point of care without needing modified data collection or clinician input in the EHR process. This
project will resolve disconnects in MVP risk assessment and treatment, providing decision tools that can be
clinically implemented for standardized MVP risk assessment to achieve the healthiest MVP outcomes possible.

Public health relevance
PROJECT NARRATIVE This project will examine mitral valve prolapse and co-occurring morbidities to enhance the clinical identification and treatment of cardiac valve diseases in people with risk factors that may result in poor cardiovascular health outcomes. Specifically, the project will describe the natural history of valve disease and resulting major adverse health events among people with mitral valve prolapse and a range of potentially complicating factors and will assemble that information to derive feasible multivariable methods for stratifying risk. The knowledge produced by this project will inform future public health initiatives and clinical care processes that aim to promote the healthiest possible outcomes in people with underlying mitral valve disease.